Development of a 3D neurovascular unit for in vitro modeling of subarachnoid hemorrhage and screening therapies

Project Summary
In this MOSAIC K99/R00 Pathway to Independence application, Dr. Brian O’Grady proposes training in
models of subarachnoid hemorrhage (SAH) and development of therapeutics that will strategically compliment
his expertise in the development of arteriole-specific growth of ex vivo brain tissue in a biomimetic hydrogel and
3D printed microfluidic fabrication. The training plan is paired with scientific studies that will develop and apply a
novel microfluidic device for modeling subarachnoid hemorrhage stroke events and for use as a screening
platform for a dual-targeted nanoparticle as a potential therapeutic for the damage caused by SAH and delayed
cerebral ischemia. Dr. O’Grady’s primary goal is to become an independent researcher focused on
creating biomimetic in vitro models of the brain vasculature and developing novel therapeutics for
neurological diseases. The rigorous training described and the outstanding team of mentors in vascular biology
(Dr. Lippmann), neurological disease pathology (Dr. Jefferson), and nanoparticle development and therapeutics
(Dr. Duvall) will ensure his success in transitioning to independence. Through his training plan, Dr. O’Grady will
gain 1) deeper knowledge of blood-brain barrier physiology and the neurovascular unit; 2) experience
synthesizing and characterizing nanoparticles; 3) knowledge of modeling SAH and neurological disorders in
vitro; and 4) strategies for running a successful interdisciplinary and collaborative research lab.
SAH is defined as a cerebrovascular disease with the initial event of a ruptured brain aneurysm and accounts
for 5% of all types of strokes. Despite this small percentage, SAH accounts for one third of all stroke-related
years of potential life lost before the age of 65. While a new era of neurocritical care management has contributed
to improved outcomes for SAH, the secondary consequences result in delayed cerebral ischemia (DCI). DCI has
varying degrees of patient functional outcome and has no known interventions to improve quality of life. This
lack of effective treatments is largely attributed to the high failure rate of translating brain-targeting drugs from
animals to humans. Recently, there has been a global effort to produce a tissue engineered, in vitro model
system that can represent the complex vascular anatomy and microenvironment of the neurovascular unit. Dr.
O’Grady’s preliminary work demonstrates that a novel biomimetic hydrogel supports induced pluripotent stem
cell-derived neural, mural, and glial cells and induces arteriole-specific growth of ex vivo human brain
vasculature. This new vasculature consists of anatomically correct, concentric layered structures that were
previously unobtainable. When supported by a microfluidic device, the arterioles anastomose and can be lumen-
perfused and photoablated. Based on his preliminary data, Dr. O’Grady hypothesizes that the dynamic
neurovascular microenvironment of a stroke-like event can be accurately modeled by this new in vitro system.
In addition to developing a new in vitro model of SAH, this project will test and validate the neural protective
efficacy of a dual-targeted therapeutic for SAH and DCI in the human in vitro model.

Public health relevance
Project Narrative Subarachnoid hemorrhage (SAH) is estimated to account for 25% of all cerebrovascular disease-related deaths and has a survivability rate of only 50% within 30 days of the initial event due to delayed cerebral ischemia (DCI). All clinical trials for treatment of DCI have been unsuccessful because promising therapies in preclinical models have all failed to translate to humans. The overall goals of this research are to 1) validate the lumen-perfusable, vascularized, microfluidic model system using ex vivo human brain tissue that fully recapitulates the complex multi-cellular hierarchy and cell interactions required to sufficiently model SAH and DCI and 2) develop, characterize, and assess the neuroprotective efficacy of a novel dual-targeted nanoparticle therapeutic after inducing an SAH and DCI event in the vascularized microfluidic model.